Uncovering the Signaling Mechanisms Underlying Treatment Failure in Medulloblastoma

ABSTRACT
Pediatric brain tumors are the leading cause of cancer-related deaths in children, with medulloblastoma (MB)
being the most common type. Despite advances in MB treatment, tumors recur in approximately 30% of children.
Virtually none of the patients with recurrent MB survive beyond one year, highlighting the need to better
understand the mechanisms underlying treatment failure. In addition to changes in the mutational landscape at
relapse, inherent tumor heterogeneity hinders the success of current therapeutic approaches for MB patients. In
line with this concept, our data suggest that small populations of astrocyte and oligodendrocyte progenitor cells
underlie the relapse of Sonic Hedgehog (SHH) subgroup MB when exposed to compounds acting on SHH
signaling, as well as to chemotherapy. Despite their likely involvement in treatment failure and MB relapse, the
signaling mechanisms allowing these glia-committed progenitor cells to propagate remain elusive. Here, we
propose to uncover the mechanisms enabling these cells to expand in response to therapies, with the specific
goal of identifying potential drug targets. Furthermore, we will assess the effectiveness of combining compounds
that block bulk MB growth with those that control the propagation of glia-committed progenitor cells. Our studies
will establish the mechanistic foundation for the development of future therapeutic approaches to enhance the
efficacy of compounds attenuating MB growth, ultimately aiming to secure long-term remission.

Public health relevance
PROJECT NARRATIVE Despite the aggressiveness of current therapies, relapses occur in approximately 30% of children with medulloblastoma. Most children with recurrent medulloblastoma die within a year, underscoring the need to uncover the mechanisms behind treatment failure and disease recurrence. Accordingly, our project aims to identify the signaling regulators that allow glia-committed progenitor cells to evade therapies and lead to medulloblastoma relapse.